FEV1 Variability as a Novel Mortality Biomarker

Lower Baseline-FEV1 (cross sectional forced expiratory volume at one second at the beginning of longitudinal
follow-up) and FEV1-slope (decline in FEV1 over longitudinal follow-up) are mortality risk factors in FDNY World
Trade Center exposed rescue and recovery workers. During our investigation of FEV1-slope and mortality, we
observed increasing FEV1 visit-to-visit variability is a previously unreported mortality risk factor. We define
FEV1 visit-to-visit variability as the standard error of the FEV1-slope modeled by linear regression. Each
doubling of FEV1 visit-to-visit variability increased mortality hazard by 22% in the FDNY cohort (Hazard ratio
(HR) 1.22, 95% confidence interval (CI): 1.13-1.33 p<.001). Similarly, in an independent community-based
replication cohort, doubling FEV1 visit-to-visit variability increased mortality hazard by 17% (HR 1.17, 95%
CI:1.14-1.20 p<.001). Inhaled corticosteroids and long-acting beta agonists (ICS/LABA) treated lung injury in
2,209/11,745, 18.8% of the cohort. A feasibility study of 284/2,209,12.5% of those treated for more than two
years, assessed if FEV1 visit-to-visit variability is useful as a treatment outcome measure after ICS/LABA
initiation. We define response to ICS/LABA as a decrease in FEV1 visit-to-visit variability after treatment
initiation (ratio pre/post FEV1 visit-to-visit variability >1). Forty percent (113/284) of the patients in the feasibility
study responded to ICS/LABA treatment. Compared with treatment non-responders, responders had a trend to
91% lower mortality odds (OR 0.09, 95%CI. 0.01-1.40 p=0.09). These data are consistent with this R21’s
hypothesis: FEV1 visit-to-visit variability is a mortality risk factor and ICS/LABA can improve FEV1 visit-to-visit
variability. When compared to ICS/LABA non-responders, ICS/LABA responders, who reduce visit-to-visit
variability after ICS/LABA initiation, will have lower mortality. AIM1 will assess the sensitivity and specificity of
mortality prediction models that already incorporate well-accepted risk factors of baseline-FEV1 and FEV1-
slope to test the hypothesis that adding visit-to-visit FEV1 variability improves their sensitivity and specificity.
Aim 2, will use patients as their own controls to determine if ICS/LABA treatment reduces FEV1 visit-to-visit
variability and will assess if response to ICS/LABA treatment is associated with reduced mortality. If the data
developed in this R21 demonstrates that FEV1 visit-to-visit variability is a mortality risk factor and that treatment
response is associated with lower mortality after controlling for well-accepted risk factors including baseline-
FEV1 and FEV1-slope, then those with elevated FEV1 visit-to-visit variability who have not been treated could
have pulmonary evaluation for consideration of ICS/LABA treatment. This grant’s focus on FEV1 visit-to-visit
variability is novel and critically important because it may predict mortality and assess treatments to modify
outcomes early in the disease course when treatment is more effective.

Public health relevance
Project Narrative We will use measures of lung health prior to and around the time of the World Trade Center collapse and the change in lung health since the World Trade Center collapse to better understand the risk of dying in the cohort of FDNY World Trade Center exposed rescue and recovery workers. A mortality risk model can identify those at greatest risk for death and facilitate evaluation for treatment of lung injury with standard medications for asthma and COPD with the goal of reducing death in this population.